The Role of an Effort-Reward Imbalance in Cognitive Fatigue

PROJECT SUMMARY
Fatigue is one of the most common symptoms in neurological and psychiatric syndromes. However, its nature
has made it one of the most controversial and least understood phenomena despite its prevalence. The
primary goal of this proposal is to test a novel theoretical approach to understanding fatigue, beginning with
cognitive (mental) fatigue. Specifically, this proposal tests a model based in neuroscience and uses
neuroimaging as a means to measure and understand the neurologic circuits underlying cognitive fatigue,
which directly aligns with NCCIH’s objectives to advance the understanding of and support the development of
novel models and methodologies to understand the neurological aspects of hard-to-manage symptoms.
Background: Patients with clinical syndromes generally report the cognitive component of fatigue to be the
most distressing aspect of their fatigue, affecting their ability to engage in work and making activities of daily
living more difficult. Previous research has examined the influence of reward and effort separately on cognitive
fatigue; however, these processes have not been integrated explicitly to test whether the interaction between
effort and reward induces cognitive fatigue. To address this gap, this study aims to evaluate whether an effort-
reward imbalance, a model based in cognitive neuroscience, could explain cognitive fatigue in a neurological
population, namely multiple sclerosis (MS), in which cognitive fatigue is a pervasive symptom. This study will
use self-report measures of fatigue, a computerized switching-task, and modern neuroimaging techniques.
Notably, the switching-task manipulates both levels of cognitive control (to induce changes in effort) and
reward to explain cognitive fatigue. Objectives: We hypothesize that cognitive fatigue results from a mismatch
between effort and reward processing. We will test the specific hypotheses that (1) across conditions of an
effort-demanding cognitive control task with different levels of reward, the effort-reward interaction will predict
cognitive fatigue and (2) fronto-striatal circuit anatomical integrity and recruitment of fronto-striatal regions will
be associated with the effort-reward tradeoffs and cognitive fatigue. Methods: The current study will recruit 20
right-handed individuals, 18 to 60 years old with a pre-existing diagnosis of MS (remitting-relapsing subtype)
with reported complaints of cognitive fatigue, and 20 age, education, and sex-matched healthy controls
meeting all inclusion criteria. In a within-subjects design, subjects will provide responses on psychosocial,
neuropsychological, and subjective fatigue measures. A DTI scan and fMRI data will be collected during a
computerized switching task with independent effort and reward manipulations. Implications: If cognitive
fatigue results from combinations of dysfunctional cognitive control and reward processes, evidenced by both
behavior and pathophysiology, we could develop a model to predict cognitive fatigue trajectory and provide a
means to guide development of assessment and interventions of cognitive fatigue in MS and other syndromes.

Public health relevance
PROJECT NARRATIVE Fatigue, specifically mental (cognitive) fatigue, is commonly reported in many clinical syndromes, including multiple sclerosis, and contributes substantially to decrements in quality of life, work, and disability in these diseases, with no reliable treatments. The proposed research will test a model of cognitive fatigue from cognitive neuroscience using neuroimaging techniques and computerized testing. If successful, this research could provide a new understanding of the basis of cognitive fatigue and lead to assessments and treatments that reduce the burdens of fatigue in patients.